University of Michigan Kidney, Urology and Hematology Research Training Network

ABSTRACT/PROJECT SUMMARY
The University of Michigan (UM) Kidney, Urology and Hematology Research Training Network (KUHR) was
developed with the primary goal of creating an institutional infrastructure with resources to aid recruiting and
preparing a diverse group of trainees (predoctoral to physician scientists and PhD postdoctoral fellows) for
academic careers. The Program faculty mentors and trainees will pursue a broad translational science
spectrum from the biological basis of disease to interventions that improve the health of individuals and the
public in the KUH domain. The U2C component will coordinate and provide administrative support through its
Administrative Core to achieve the goals of the Program, structured around the following Specific Aims. Aim 1:
To train the next generation of scientists in KUH relevant areas. The TL1 component supports a rigorous
training program emphasizing research training themes based both on the critical need to develop well-trained
investigators in all areas along the translational and cross-disciplinary spectrum of KUH disease research and
on the investigative interest and expertise of program faculty members. In addition to UM, Program faculty
members are drawn from a regional research base involving the University of Toledo, Ohio and institutions
across the State of Michigan. Trainees focused on basic research will participate in an intensive pre or
postdoctoral research training program. Trainees focused on more translational or health services research will
often pursue a Master's Program in Clinical Research Design and Statistical Analysis, Bioinformatics, Health
and Health Care Research or Health Infrastructures and Learning Systems. Aim 2: To assist trainees with
developing the skills broadly necessary for a successful career in research. Offerings from the
Professional Development Core will support activities and curricula designed to enhance trainee research
competitiveness in research, including building skills in leadership and communication, grant writing and
professional networking. Aim 3: To ensure the provision of robust and skillful research mentoring. The
Professional Development Core will also include specific curricula directed at preceptors to develop their
mentoring skills. Another important component, the Networking Core will develop systems and processes that
support direct peer communication and near-peer mentoring amongst all trainees supported directly by the TL1
component of this award, as well as those institutional trainees already supported by other NIH training
mechanisms. Aim 4: To establish a pipeline for future trainees fostering diversity, equity, and inclusion.
Community outreach to attract diverse early-career students (high school and undergraduate) into KUH
research areas is another important focus of the Networking Core. The ultimate goal of the Program is to
attract, recruit, provide networking opportunities, engage and prepare trainees for academic KUH disease
research careers in the United States.

Public health relevance
PROJECT NARRATIVE The goal of the University of Michigan Kidney, Urology and Hematology Research Training Network is to establish an infrastructure to enable the recruitment and training of predoctoral and postdoctoral trainees. The Program will provide trainees with the skills necessary to pursue careers in research so that they can contribute to the development of advances in the prevention, diagnosis, and treatment of KUH diseases. This training program fills a critical need to increase the number of future leaders in KUH research.